AAV-CRISPR engineering brown-like adipocytes targeting obesity and metabolic disorders

Abstract
Obesity and metabolic disorders prevalence has increased dramatically over the last decades. Obesity is a major
risk factor for type II diabetes mellitus, hypertension, cardiovascular disease, osteoarthritis, and certain forms of
cancer. Despite years of intense studies, there is still substantial need for safe, more effective and more
convenient therapeutics for treating obesity. Developing a novel bioengineered brown adipocyte transplant may
offer a new paradigm for treating obesity and associated metabolic disorders, which can complement the current
standards of care. The present STTR collaborative consortium is based on our previous successfully developed
proprietary technologies to generate highly potent brown adipocyte-like cells, so-called HUMBLE cells, from
abundantly available white preadipocytes, by using the innovative CRISPR/dCas9-SAM technology. The
HUMBLE cells have demonstrated potentially superior efficacy and persistency in vivo than other brown-like
cells. The present Phase I study aims to further develop a safer and efficient episomal AAV vector to replace our
previous lentiviral system and investigate the applicability of the AAV system to donor-derived, non-immortalized
white preadipocytes to mimic real clinical use. The present study will generate new CRISPR-engineered, safer
HUMBLE cells suitable for clinical development. Success of the technology will lead to new therapeutics
addressing the obese patient needs that existing pharmaceuticals cannot adequately address.

Public health relevance
Project Narrative By 2030, more than 50% Americans will suffer from obesity, resulting in millions of new cases of diabetes, coronary heart disease, and stroke -- a constellation of illness that could cost the United States up to $66 billion in treatment and over $500 billion in lost economic productivity. Developing a novel bioengineered brown like adipocyte transplant may offer a new paradigm for treating obesity and associated metabolic disorders.